ZIDOVUDINE, DIDANOSINE AND DOUBLE-BLIND NEVIRAPINE VS COMBINATION ZID/DIDA

A comparative study of a combination of zidovudine, didanosine and double blinded nevirapine versus a combination of zidovudine and didanosine.